Consortium for Immunotherapeutics against Emerging Viral Threats

SUMMARY: OVERALL
This proposal, Consortium for Immunotherapeutics Against Emerging Viral Diseases, addresses a critical
gap in the biodefense portfolio by building an academic-industry partnership to advance effective, fully human,
antibody-based immunotherapeutics against three major families of emerging/re-emerging viruses: Lassa virus,
Ebola and other Filoviruses, and mosquito-transmitted Alphaviruses that threaten millions worldwide. This
program follows directly from our significant body of preliminary data (the largest available for these families of
viruses), therapeutics in hand, multidisciplinary expertise, and demonstrated collaborative success. Included in
the proposed CETR portfolio are: (1) the only available immunotherapeutics against endemic Lassa virus, with
reversal of late-stage disease and complete survival in infected non-human primates, (2) novel Ebola and pan-
ebolavirus therapeutics that also completely protect non-human primates from disease, and that were built by
the paradigm-shifting and comprehensive analysis of a global consortium, and (3) much needed, first-in-class
therapeutics against the re-emerging alphaviruses that have tremendous epidemic potential in the United States
and around the globe. These multidisciplinary studies, founded upon pioneering structural biology of the antigen
targets, include innovations such as agnostic, high-throughput Fc profiling and optimization, coupled with Fv
evolution to enhance potency and developability, as well as a sophisticated statistical and computational analysis
core to evaluate thresholds and correlates of protection across the major families of pathogens. Together, we
aim to understand what findings represent general rules and what data are specific to each virus family. We also
aim to provide streamlined systems for antibody choice and optimization that do not yet exist, and to build a
broadly applicable platform for mAb discovery and delivery against any novel pathogen as they emerge. The
recent resurgence of Lassa, the epidemic nature of Ebola virus and other re-emerging filoviruses, as well as the
major population at risk by global movement of mosquito-borne alphaviruses together demonstrate the
tremendous global need for immunotherapeutics developed and advanced by this program.

Public health relevance
NARRATIVE Three major families of emerging viruses (Lassa and other arenaviruses, Ebola and other filoviruses, and mosquito-borne alphaviruses) threaten human health worldwide, but lack approved therapeutics or vaccines. The proposed multidisciplinary consortium, an academic-industry partnership, will advance safe and effective, fully human, monoclonal antibody therapies against these viruses, using candidate therapies that confer complete protection in non-human primates as our starting point. Our collaborative databases, multivariate analyses and innovative antibody optimization strategies will establish platforms for discovery and delivery of much-needed treatments against these and other infectious diseases.